Regulation of y-secretase activity by modulatory proteins

Mutations in presenilin-1 (PS1) or Presenilin-2 (PS-2), the catalytic subunit of γ-secretase, lead to the early-
onset form of Alzheimer’s disease (EOAD). However, the causes of late-onset AD (LOAD) are under active
investigation. The pathological features and functional connectivity of both forms of AD are similar, suggesting
that γ-secretase may play a causative role in the late-onset form of AD. Moreover, the pathological role of γ-
secretase in EOAD has not been fully elucidated. Only a small fraction of the γ-secretase complex is catalytically
active and the function and activation of the inactive complex is unknown. The objectives of this proposal are to
elucidate the mechanism of action of γ-secretase modulatory proteins (GSMPs) in the regulation of γ-secretase
and examine their function in AD. Here we propose to investigate how γ-secretase activity is activated by
cerebrovascular disease mediated hypoxia and γ-secretase activating protein (GSAP). We will elucidate the
molecular basis of GSAP in modulation of γ-secretase for the processing of APP and Notch1. We will determine
the underlying mechanism by which Hif1α activates γ-secretase. Lastly, we will investigate the mechanisms by
which GSAP- and Hif1α- regulate γ-secretase activity in AD mouse models. The long-term goals of this proposal
are to elucidate the mechanism of γ-secretase modulation and identify novel γ-secretase regulatory proteins as
well as assess their relevance to AD. Our studies focus on the molecular basis of γ-secretase modulation by
modulatory proteins and have potentially significant impacts on understanding the disease mechanism and
developing therapeutics.

Public health relevance
Abnormal γ-secretase activity causes the early-onset form of Alzheimer’s disease (AD). This proposal investigates the mechanism of γ-secretase activation under pathophysiological conditions that increase risk for AD. This application addresses unmet needs in AD research with clear mechanistic insights and translational potentials.